Hematopoietic Stem Cell And Cord Blood Transplantation

PROJECT SUMMARY/ABSTRACT
Hematopoietic cell transplantation from unrelated donors, haploidentical related donors and cord blood units
can cure life-threatening blood disorders; however, graft-versus-host disease (GVHD), relapse and
survivorship disparities across different ancestries remain the major obstacles. When matched donors are not
available, the properties of HLA mismatches that govern (non)-permissivity are not well-defined. Furthermore,
the role of KIR/HLA interactions in modulating relapse remain to be clarified. These deficiencies have important
implications for a large fraction of patients who lack HLA-matched donors, and for all patients at risk for
disease relapse. We have demonstrated that HLA class I leader peptides, HLA-DP expression, and HLA/KIR
interactions each contribute to GVHD, relapse and mortality. The unmet needs are to understand the
mechanisms through which HLA and KIR genes modulate transplant risks, and a means to apply the research
findings to clinical care. We propose to define the underlying mechanisms through which HLA and KIR genes
and proteins function in transplantation, and develop tools for using HLA and KIR in the selection of the optimal
transplant donor and cord blood unit. The specific aims are to: define the role of HLA-DP expression and
peptide-binding groove pocket in GVHD; define NKG2/HLA-E interactions and HLA-G in GVHD and relapse;
define the role for KIR and HLA interaction in relapse after HCT for acute leukemia, and design tools to
evaluate gene features in clinical practice. The goals will be achieved through systemic analysis of individual
gene variation, haplotypes of genes, and receptor/ligand recognition in large ethnically diverse transplant
populations with complete clinical data. This proposal will fill the knowledge gap in the immunobiological basis
of GVHD, relapse and survivorship disparities in transplantation. The information will increase the safety,
efficacy and availability of transplantation for all patients in need of this life-saving therapy.

Public health relevance
Project Narrative We will study how immune system genes affect the success of transplantation for patients of diverse ancestries. This information will help to lower risks through individualized treatment options for future patients.